Prevention of anthracycline-induced cardiotoxicity by Nur77 activation

Project summary
Doxorubicin (Dox), an anthracycline chemotherapeutic, is a well-established and highly effective chemotherapy
drug commonly used to treat multiple cancer types, but its use is limited by cardiotoxicity. Patients with Dox
therapy often develop delayed cardiomyopathy for which no effective therapies exist. The molecular
mechanisms of this drug toxicity remain poorly understood and are likely to be multifactorial. DNA damage,
mitochondrial dysfunction, p53 activation, and excessive cardiomyocyte apoptosis are major contributors to the
pathogenesis of Dox-induced cardiac toxicity, but whether a pharmacological strategy can simultaneously work
to reverse all of these events in patients that receive Dox treatment has yet to be uncovered. Our laboratories
have a long track record in studying the role of nuclear receptor 4A (NR4A) biology in cardiovascular
homeostasis and disease. In recent work, we have generated a significant body of evidence to support the
novel concept that reduced cardiac expression of Nur77, a family member of NR4A receptors, plays a causal
role in the pathogenesis of Dox cardiomyopathy. We have found that 1) Cardiac expression of Nur77 is
significantly reduced in Dox treated cardiomyocytes and hearts and that 2) Cardiac specific overexpression of
Nur77 effectively prevents Dox induced cardiac dysfunction, cardiomyocyte apoptosis, and fibrosis. In addition,
we have identified DNA topoisomerase IIβ-binding protein 1 (TopBP1) as a key downstream effector of Nur77
in the heart, and have found that its expression is substantially reduced in Dox-treated hearts. More importantly,
our preliminary data indicate that Nur77 prevents cardiac toxicity by inducing TopBP1-topoisomerase IIβ
(Top2β) interactions, which in turn effectively shields Top2β/genomic DNA from Dox-induced damage in the
heart. These data led us to hypothesize that Nur77 serves as an important cardioprotective agent and that
targeted activation of Nur77 can effectively prevent Dox-induced cardiomyopathy while having minimal to no
effects on its anti-cancer behaviors. We will test this hypothesis in the following three aims. Aim 1 will perform
loss-of-function studies by employing Nur77 cardiac specific knockout mice (cNur77-KO) to determine whether
cardiac specific deletion of Nur77 exacerbates Dox-induced cardiotoxicity through enhanced apoptosis, fibrosis,
and inflammation in the heart. Aim 2 will determine the underlying mechanisms by which Nur77 exhibits its
cardioprotective effects against Dox-induced cardiac injury. Cardiac specific TopBP1 transgenic and knockout
mice will be used to assess the contribution of TopBP1 to the Nur77-initiated cardiac protection in mouse
models of Dox cardiotoxicity. Aim 3 will study whether pharmacological activation of Nur77 holds the capacity
to block Dox cardiomyopathy without compromising anti-cancer activity of the drug. Successful completion of
these aims will guide us to develop new therapeutic agents to prevent selective toxicity of anticancer drugs to
the heart. The predicted utility and feasibility of such targeting in humans favors the translational potential and
ultimate impact of the proposed studies.

Public health relevance
Project Narrative Doxorubicin (Dox) is among the most effective and widely used drugs for treatment of human cancers. Unfortunately, Dox induces life-threatening cardiotoxicity including cardiomyopathy and heart failure. Our studies aim to understand the key factors that cause this problem and understanding these processes will allow development of new drugs to treat the problem in the future.